An informatics framework for single-cell multi-omics from clinical specimens

PROJECT SUMMARY
The proposed supplemental activity is within the scope of parent award. No changes to the project summary.

Public health relevance
PROJECT NARRATIVE The proposed supplemental activity is within the scope of parent award. No changes to the project narrative.